NON-INVASIVE OXIMETRY IN MONITORING OF CRITICALLY ILL CHILDREN

The purpose of this study is to investigate the use of a new ear oximeter (BIOX oximeter) for monitoring oxygenation in critically ill patients.